Theranostic CAR-T Targeting Senescence in Alzheimer's

Project Summary / Abstract
The increasing elderly population is resulting in a rise in age-related disorders. More than 95% of
Alzheimer's disease (AD) instances are observed in individuals aged 65 or above, impacting over 11% of
people within this age group. Cellular senescence is a key player in the aging mechanisms and plays a role in
the onset of various age-related conditions, including AD, AD-related dementias (ADRD), and other
neurodegenerative disorders. The removal of senescent cells has shown encouraging therapeutic results as a
promising direction in reversing senescence and aging associated pathologies. Detecting and imaging
senescent cells is critical for understanding the mechanisms of aging and associated disorders, and for guiding
the removal of senescent cells. In addition to small molecule-based senolytics, the chimeric antigen receptor
(CAR) T cell immunotherapy has recently been successfully applied as a novel strategy to target senescent
cells in cancer and fibrosis models. However, CAR T cells in general suffer from various off-site toxicities,
which represent a major impediment for a broader application of CAR T cell therapies. We propose to develop
a novel concept of theranostic (therapeutic and diagnostic) CAR T cell platform based on unique theranostic
probes and the signal-sensing chemically-induced proximity (sCIP) technology that selectively detect/report
senescent cells, and also allows CAR T cells to respond to both “senescence-associated surface antigens”
(on-target) and “senescence-associated chemical reactivities” that are presented within senescent cells (on-
site), while limiting off-site activation of CAR T cells and the associated toxicities. To demonstrate this novel
theranostic CAR T strategy, we propose to incorporate abscisic acid (ABA)-based sCIP technology to create
and test theranostic ABA inducer that respond selectively to senescence-associated b-galactosidase (SA-b-
Gal) and different CAR constructs specific to urokinase plasminogen activator surface receptor (uPAR) antigen
on senescent cell surface. An additional inducible gene expression cassette introduced in CAR T cells can
selectively produce therapeutic proteins in situ upon SA-b-Gal stimulation. In R61 phase, we will develop the
theranostic CAR T platforms, which include the senescence-responsive theranostic ABA inducer (Aim 1), and
the development of split CAR (sCAR) T cells and evaluate their efficacy in vitro (Aim 2). Since AD mice model
will be used in the next phase and it takes time to develop, we will also start establishing AD mice models and
colonies (Aim 3). In R33 phase, we will evaluate the theranostic ABA inducer (Aim 4), and the activation of
sCAR-T in AD mice models (Aim 5). The efficacy of the theranostic CAR T therapy will be evaluated in AD
mice using behavioral assays and MRI (Aim 6). We anticipate that our novel approach will have a broad impact
on the development of AD therapeutics and it will also advance both senotherapies and CAR T therapies.

Public health relevance
PROJECT NARRATIVE Public Health Relevance Statement: Cellular senescence, a key biological process underlying aging, contributes to Alzheimer's disease (AD), AD- related dementias (ADRD) and various aging-related diseases. Chimeric Antigen Receptor (CAR) T cell immunotherapy has demonstrated great potential for treating human disease and offers a new direction to target senescence and reverse the associated pathologies in AD/ADRD. We aim to develop a novel theranostic CAR T platform that selectively senses multiple senescence signals to simultaneously report senescence and activate CAR T cells to eliminate senescent cells, offering a precise and effective diagnostic and therapeutic system targeting senescence in AD/ADRD.